Identifying and exploiting molecular abnormalities of tumor vasculature

PROJECT SUMMARY
Cancer remains the second leading cause of death in the USA, with ~600K lives lost in 2022. Therefore, there
remains an urgent need to develop new therapies or enhance existing therapies for cancer patients. A major
focus of such efforts is understanding how variability in the tumor microenvironment affects treatment efficacy.
Increasingly, the aberrant properties of tumor vasculature are recognized as barriers to efficient delivery and
distribution of bloodborne therapies. Although it has long been known that tumor blood vessels exhibit morpho-
logical and functional differences from normal blood vessels, the molecular bases for these features have not
been firmly established. The purpose of this application is to test the hypothesis that vascular cells from di-
verse human cancers share molecular phenotypes that can be exploited as biomarkers and for therapeutic
purposes. In Aim 1, we will identify molecular markers that optimally distinguish tumor vasculature from normal
vasculature by performing integrative gene coexpression analysis of bulk transcriptomes representing tens of
thousands of samples from cancerous and normal human tissues. We will also validate candidate markers his-
tologically and functionally. In Aim 2, we will determine whether loss or inhibition of ENPEP, a marker of glio-
blastoma (GBM) vasculature, promotes favorable outcomes in orthotopic mouse models of this disease. We
will compare tumor progression and survival between Enpep -/- and wild-type mice using a murine allograft
model of GBM. Using allograft and xenograft models of GBM, we will also evaluate the anti-tumor efficacy of
firibastat, a first-in-class, brain-penetrating, oral prodrug that selectively inhibits ENPEP. In Aim 3, we will de-
velop and validate novel antibodies for binding cell-surface markers of tumor vasculature. We will employ an
industrialized phage display platform to generate panels of recombinant antibodies that target cell-surface
markers of tumor vasculature and validate antibody specificity and functional significance using in vitro and in
vivo assays. Expected outcomes include identification of optimal markers of tumor vasculature in diverse hu-
man cancers, clarification of the role of ENPEP in GBM progression, and development of novel zip code rea-
gents for targeting tumors via the bloodstream with potential applications as biomarkers or therapeutics.

Public health relevance
PROJECT NARRATIVE Cancer remains the second leading cause of death in America. This project uses computational and experimental strategies to identify molecular abnormalities of tumor blood vessels and develop new strategies for targeting them. This information will help enhance existing cancer therapies and develop new therapies.